SQLE and Sterols Contribute to Racial Disparity in ER+ Breast Cancer Patient Survival

ABSTRACT
The racial disparity in breast cancer survival rates has largely been attributed to late-stage diagnoses and
increased incidence of triple negative breast cancer in African American (AA) compared to non-Hispanic White
(white) women. However, the latest statistics indicate that more than 50% of tumors in AA women are estrogen
receptor positive (ER+). ER+ tumors are considered less aggressive and are typically treated effectively with
endocrine therapies that target ER activity (i.e. tamoxifen) or estrogen production (i.e. aromatase inhibitors).
Despite a generally favorable prognosis for women with ER+ breast cancer, AA women still have a greater risk
than white women of dying from ER+ disease. We have found that AA women in the Chicago area have a 4 to
5-fold greater risk of death from ER+ breast cancer than white women, even after controlling for stage at
diagnosis, treatment, and other known prognostic factors. This finding implies that biologic mechanisms are
activated in ER+ breast cancer from AA women, resulting in resistance to endocrine therapy and a greater risk
of relapse and death. Our overarching goal is to identify biological and molecular mechanisms contributing to
the racial survival disparity in ER+ breast cancer patients. The goal of this proposal is to investigate the role of
SQLE (squalene epoxidase), a key enzyme in the biosynthesis of sterols, cholesterol, and oxysterols, as a
potential driver of poor outcome in AA women with ER+ tumors. We hypothesize that elevated SQLE in ER+
tumors of AA women leads to an accumulation of biologically active sterols that function to promote tumor cell
proliferation and survival. Mechanistically, we expect these sterols to function by altering ER activity and reducing
responsiveness to endocrine therapies. To investigate this, we propose 3 aims: 1) to define the mechanism by
which SQLE is up-regulated in ER+ breast tumors in AA women; 2) to identify SQLE-regulated sterols that are
associated with race in ER+ breast tumors, and 3) to assess the cellular function and therapeutic potential of
SQLE in ER+ tumors of AA women. To accomplish these aims, we will utilize newly generated tumor collections
and novel preclinical models from AA women, as well as an innovative method we developed to detect and
analyze multiple sterol species. Overall, we expect to establish SQLE as a critical player in the racial disparity
observed in survival of patients with ER+ breast cancer. Importantly, we expect to uncover two new mechanisms
that may explain i) how SQLE contributes to early relapse and ii) why SQLE expression is elevated in ER+
tumors of AA women. Ultimately, this work has the potential to increase health equity by improving survival for
AA women with ER+ breast cancer through the development of novel preventive and treatment strategies that
target underlying molecular mechanisms contributing to disparate outcomes.

Public health relevance
PROJECT NARRATIVE The proposed work will investigate SQLE, as well as SQLE-regulated sterols, as novel players in the survival disparity observed in patients with ER+ breast cancer. This work has the potential to increase health equity by improving survival for AA women with ER+ breast cancer through the development of novel preventive and treatment strategies that target underlying molecular mechanisms contributing to disparate outcomes.